University of Maryland BaltImore Life Science Discovery (UM-BILD) Accelerator

PROJECT SUMMARY/ABSTRACT
The goal of the University of Maryland BaltImore Life Science Discovery Accelerator (UM-BILD) is to create a
new NIH Research Evaluation and Commercialization Hub (REACH) program that serves as a development
engine to build the life science economy in West Baltimore and Greater Baltimore and to train one of the most
diverse biomedical and entrepreneurial workforces in the US. Underrepresented minorities (URM) making up
34% of the population, URMs comprise only 15% of PhD graduates and 4% of tenured faculty positions in
medical schools. Diversity amongst venture-backed founders is even less. This is in the face of evidence that
increased workforce diversity increases productivity, financial performance, and employee satisfaction. UM-BILD
will be formed from a partnership with University of Maryland Baltimore (UMB), University Maryland School of
Medicine (UMSOM), University of Maryland Baltimore County (UMBC) (a Minority Serving Institution), University
of Maryland College Park, Morgan State University (a Historically Black College/University (HBCU)), Blackbird
Laboratories ($100MIL life science institute/incubator), and the Maryland Innovation Initiative (MII). All Baltimore
universities and life science innovators will have access to hub expertise, resources, and networking. UM-BILD
will directly address the need for increased biomedical and startup workforce diversity leveraging existing,
successful initiatives at UMSOM and UMBC. UM-BILD will foster life science industry growth of the
demographically diverse (28% African American and 7% Hispanic) Baltimore Region. UM-BILD will embrace
existing partner programmatic efforts to increase biomedical workforce diversity; as well as direct engagement
with HBCU’s and Minority serving institutions. UM-BILD will solicit, identify, and develop early-stage life science
platforms and projects over the entire spectrum of technology types. UM-BILD will have three specific aims: Aim
1: Provide seed investment and development resources for 11 early-stage technology projects teams per year
enhanced by a $5 million non-federal match funds through partner institutions and MII. Technologies will receive
milestone gated investments of up to $200,000 and access to unique biomedical development facilities at UMB
and UMBC to serve as a dedicated incubator. Aim 2: Train a diverse biomedical and innovation workforce from
elite scientists and innovators. We will offer a dedicated entrepreneurial, project management, and business
development curriculum that will build upon on-going biomedical workforce diversification programs at UMB and
UMBC, and the Baltimore region in general, to allow for a unique cohort of newly trained life science
entrepreneurs, many from URM backgrounds. Aim 3: Create new companies ready to apply for federal
SBIR/STTR awards and raise private capital to grow the life science economy in Baltimore. UM-BILD will provide
services in company formation, training in obtaining federal innovation grants; connections to investors seeking
early-stage life science opportunities (see letters of support); and subsidized space in Baltimore Bioparks.

Public health relevance
PROJECT NARRATIVE The goal of the University of Maryland BaltImore Life Science Discovery (UM-BILD) Accelerator is to create a new NIH Research Evaluation and Commercialization Hub (REACH) program that serves as a development engine to build the life science economy in West Baltimore and Greater Baltimore and to train one of the most diverse biomedical and entrepreneurial workforces in the US. Formed from a partnership by University of Maryland, Baltimore, the University of Maryland School of Medicine, University of Maryland, Baltimore County, Morgan State University, University of Maryland College Park, and the Maryland Innovation Initiative, UM-BILD will embrace existing partner programmatic efforts to increase biomedical workforce diversity such as the University of Maryland FIRST program. Enabled by a greater than $5 million non-federal match, the UM-BILD hub will: 1) provide pilot funds for commercialization-potential technologies to advance to the next stage; 2) utilize internal core services/equipment as a dedicated-life science incubator; 3) offer dedicated business training programs to diverse investigators and founders; and 4) mentor and network innovators for fundraising to further advance successful technology projects (SBIR/STTR awards, venture capital).